Probing inflammation dynamics via multi-modal tracking and control of engineered macrophages

PROJECT SUMMARY
Inflammation is a fundamental biological process that coordinates immune responses to infection, injury, and
disease. Understanding the dynamics of inflammation is essential for deciphering how immune responses shift
from protective to pathological states. Our research aims to provide mechanistic insights into these processes
to uncover therapeutic opportunities for modulating the immune system. Macrophages, due to their phenotypic
plasticity and ability to regulate inflammation, play a pivotal role in this context. Additionally, macrophage
trafficking—encompassing their movement and localization within tissues—is critical to understanding
inflammation dynamics. A core focus of our laboratory is to develop non-invasive imaging and control techniques
that allow for real-time visualization and modulation of macrophages. With support from this MIRA, we will
develop and validate a new class of engineered macrophages capable of both tracking and modulating
inflammation in vivo. By equipping macrophages with markers detectable across multiple imaging modalities—
including ultrasound, MRI, and optical imaging—we aim to achieve a comprehensive, multimodal view of
macrophage behavior at different spatial and temporal scales. This innovative approach will significantly enhance
our ability to probe inflammation dynamics and pave the way for targeted interventions that precisely modulate
macrophage activity. Furthermore, we will employ focused ultrasound technology to control the functional
responses of engineered macrophages in remote control, establishing a novel framework for understanding and
managing inflammation in living systems. This integrated strategy not only aims to enhance our understanding
of macrophage dynamics within various disease settings but also serves as a foundation for innovative
macrophage-based therapeutics, specifically aimed at reprogramming macrophage functions for restoring
immune balance in diseased environments. Our ultimate vision is to create a theranostic platform using living
cells as both therapeutic agents and imaging probes, enabling compatibility with bioacoustic, biophotonic, and
biomagnetic tracking methods and setting a new standard for the precision treatment of inflammation-related
diseases.

Public health relevance
PROJECT NARRATIVE This project aims to investigate inflammation dynamics through the development of engineered macrophages capable of both tracking and modulating inflammatory responses in vivo. By integrating multimodal imaging techniques, including ultrasound, MRI, and optical imaging, we will achieve a comprehensive understanding of macrophage behavior at various spatial and temporal scales. Ultimately, this theranostic approach envisions using living cells as therapeutic agents and imaging probes, paving the way for precision treatments of inflammation-related diseases.